Alveolar Epithelial Cell Dysfunction in Pulmonary Fibrosis: Leveraging SFTPC Mutations for Discovery of Molecular and Cellular Targets

ABSTRACT
Fibrotic lung remodeling represents the final common pathway to respiratory failure for a variety of Interstitial
Lung Diseases (ILD) in children and adults. Based on a recent paradigm shift wherein the concepts of
epithelial cell dysfunction and abnormal wound healing are postulated as “drivers” of pulmonary fibrosis, new
opportunities are emerging for therapeutic discovery for ILD. Mutations in the Surfactant Protein C [SP-C]
gene [SFTPC], an alveolar type 2 cell (AT2) restricted protein, have been found in sporadic and familial ILD
and can provide important clues for understanding the role of epithelial cell dysfunction in ILD pathogenesis.
Prior in vitro studies from our lab have shown that SFTPC mutations described in both adults and children with
ILD result in production of aberrant SP-C proprotein isoforms that adopt non-native conformations resulting in
at least 2 outcomes: ER stress and intracellular aggregation (BRICHOS) or mistrafficking to non-native
organelles and inhibition of macroautophagy (Non-BRICHOS). This application proposes to leverage two
novel knock-in mouse models of spontaneous lung fibrosis already in hand which express Non-BRICHOS or
BRICHOS clinical SFTPC mutants in AT2 cells in an allelic and inducible fashion. Our Published and
Preliminary Data reveal that expression of either a non-BRICHOS mutant (SP-CI73T) or BRICHOS mutant (SP-
CC121G) is extremely toxic to the lung in vivo with each resulting in time-dependent spontaneous lung fibrosis
marked by 3 phases: ii) early AT2 cytokine elaboration and monocyte recruitment,; (ii) a polycellular alveolitis
and lung injury; (iii) physiologically restrictive peripheral fibrotic remodeling. These models also elaborate
translationally relevant biomarkers reported in human ILD. In order to define both consensus and divergent
molecular mechanisms linking these two AT2 cell phenotypes with the downstream lung injury and fibrotic lung
remodeling, our experimental approach will be to exploit the unique features of these genetic models combined
with tools, reagents, and expertise available in our program. In 3 specific aims, we propose to comprehensively
characterize the transcriptomic and functional AT2 cell phenotypes evoked by expression of non-BRICHOS
(SP-CI73T) and BRICHOS (SP-CC121G) Sftpc mutants [Specific Aim 1], to define the role of a key
proinflammatory/profibrotic monocyte population recruited by AT2 mutant Sftpc expression in the development
of fibrosis [Specific Aim 2], and to examine changes in epithelial-mesenchymal crosstalk that disrupt alveolar
niche homeostasis and promote fibrotic remodeling [Specific Aim 3]. As epithelial dysfunction has not been
studied extensively in vivo in the context of relevant preclinical models of fibrotic lung disease, this approach
offers the unique opportunity to provide proof of concept both for the causal effect of mutant SFTPC in familial
ILD and for the role of AT2 dysfunction as a key upstream driver of inflammatory cell and fibroblast activities
that promote parenchymal remodeling. Importantly, mechanisms identified using a focused approach with
these Sftpc models can be cross-purposed to better understand the pathogenesis of sporadic forms of ILD.

Public health relevance
Lay Narrative Pulmonary fibrosis (PF), a devastating complication of interstitial lung disease (ILD) in adults and children, is marked by unrelenting tissue scarring, respiratory failure, and death for which there are currently insufficient effective medical therapies. To better understand the fibrotic processes in the lung, we developed novel mouse models expressing mutations in the Surfactant Protein C (SP-C) gene that are associated with human ILD and will use them characterize the molecular and cellular mechanisms which contribute to epithelial cell dysfunction and promote the fibrotic response. By studying these events in relevant mouse models, results funded by this project will be translatable to ILD by identifying the contributions of complex cell interactions and mediators that can be used to define new targets for PF-ILD treatments. .